Studying the mechanism of discogenic low back pain induction.

PROJECT SUMMARY
The goal of this study is to establish a human model for low back pain (LBP) caused by intervertebral disc (IVD)
degeneration, and to answer the question, what causes a degenerative disc to become painful? LBP is a leading cause of
disability and morbidity in the adult population, affecting approximately 80% of adults. Up to 40% of all LBP is attributed
to IVD degeneration, which is categorized as discogenic pain. Radiographically aged IVDs do not always correlate with
pathologically painful discs. Current treatments focus on pain management and the restoration of disc height, but the
underlining cause for discogenic pain remains untreated. In our previously published and preliminary studies we have
established an in vitro system to simulate IVD degeneration, a nociception sensing with sensory neuron differentiated from
induced pluripotent stem cells (iPSC), an in vivo bioassay using a rat model and performed single cell transcriptomics of
pain inducing and asymptomatic IVD tissues and developed a hypothesis for the pain induction mechanism. In this proposal
we will combine these systems in Nociception-Chip to unveil the molecular and cellular mechanism of discogenic pain
induction in vitro and in vivo. In Aim 1 we will identify the cellular sub-population(s) that transform asymptomatic IVDs
to discogenic pain inducing ones, test the hypothesis that this process is mediated by pro-inflammatory agents and
investigate its reversibility. The single cell data will be utilized to identify specific surface cell markers of the sub-
populations with which we will sort the cells out. We will simulate disc degeneration model in vitro and to test the
functionality of these cells, identify the critical factors that lead to development of discogenic pain and test the response of
nociceptors differentiated from induced pluripotent stem cells as a readout of pain sensing. The functionality of these cells
to induce LBP behaviour will be validated in a rat model. We will test the hypothesis that this process is mediated by specific
inflammatory factors or the lack of anti-inflammatory factors like MIR-155 by co-injecting them to a healthy or mildly
degenerated IVDs. In Aim 2 we will identify cellular sub-population(s) enriched in degenerated asymptomatic IVDs and
test the hypothesis that these cells prevent the transformation of asymptomatic to painful IVDs. We will leverage the same
database of single cell transcriptomics used in Aim 1 and will look at the non-painful disc prevalent celsl as potentially
therapiutics cells. These cells will be isolated, characterized and co-injected with pain inducing cells or to a degenerated
IVDs in a rat model that allows measurement for stractural and behavioral LBP outcomes. Overall, both aims are not
interdependant and will contain hypothesis-driven, hypthesis generating and therapituc components.
This study is significant because it will fill substantial gaps in our understanding of discogenic pain developement: establish
a controlled system in vitro to identify the main cause(s) behind discogenic pain; identify molecular signatures and point
towards potential therapeutic targets or cellular population characteristics. This study is novel, because it will elucidate the
role of IVD cells, the factors that induce discogenic pain and impactful because we will identify novel therapeutic targets
that will allow interventions beside the use of analgesics and opioids that are currently prescribed for discogenic pain.

Public health relevance
PROJECT NARRATIVE Low back pain has complex mechanism and involves multiple tissues including the spine, spinal cord and the brain. In this study we will use an in vitro model for a low back pain and in vivo bioassay, focusing on what makes one degenerative disc painful and another not. Here will utilize the human IVD tissues for single cell analysis and will to establish the mechanisms that drives specifically discogenic pain in degenerated IVDs.